PHASE II TRIAL OF SURAMIN IN METASTATIC PROSTATE CANCER

The objectives are to examine the response rate and duration of response in hormone refractory metastatic prostate cancer patients treated with suramin; to utilize an intermittent dosing schedule employing an HPLC suramin assay, pharmacokinetic modelling, MAP-Bayesian estimation and adaptive control in order to safely administer the agent; to examine the reliability and safety of this method of suramin administration and carefully monitor toxicities seen with this schedule.